Project I: Inflammation, HTN, and Long-term Effects on Maternal Well Being

Hypertension during pregnancy, such as preeclampsia (PE), is an important cause of maternal and fetal death
in the U.S. Women with PE are affected with neurological compromise, immune system dysregulation, and
increased agonistic autoantibodies to the angiotensin II type 1 receptor (AT1-AA). Circulating CD4+ T cells and
inflammatory cytokines, and the AT1-AA are all associated with hypertension and increased cerebral perfusion
pressure resulting in impaired cerebral autoregulation and increased blood-brain barrier (BBB) permeability.
Reports of increased anxiety, depression and cognitive impairment have been made in women with PE.
Experimental AT1 receptor studies suggest a possible role between the AT1-AA during pregnancy and
postpartum (PP) psychological and neurological complications. Therefore, the central hypothesis is that during
hypertensive disorders of pregnancy, the increase in immune cells (CD4+ T cells, B cells, and macrophages)
leads to increased AT1-AA-induced systemic inflammation stimulating an impairment in cerebral
hemodynamics, ultimately leading to increased BBB permeability, which is associated with anxiety, depression
and cognitive impairment during pregnancy and the PP period. Recent data from animal studies report that
increased maternal AT1-AA levels are associated with increased levels of AT1-AA in offspring. As such, we will
examine infant development among male and female children born to women in this study.
Specific Aim 1 To test the hypothesis that increases in CD4+ T cells, B cell secreting AT1-AA, and
macrophages positively correlate with cognition or mood changes during pregnancy and the PP period among
women with PE. We will use results from an assemblage of validated questionnaires designed to assess
anxiety, depression and cognitive impairment during pregnancy and the PP to determine if psychological
results correlate with immunological changes.
Specific Aim 2. To test the hypothesis that cerebral autoregulation impairment and BBB damage in women
with PE is due to increased levels of the AT1-AA, IL-17, and TNFα. An association between AT1-AA levels,
circulating inflammatory and neurovascular markers, cerebral autoregulation (measured via transcranial
doppler) and in vitro BBB assays will be determined.
Specific Aim 3. To test the hypothesis that maternal AT1-AA impacts infant development and to investigate if
these effects are dependent on sex differences. Infant development will be measured and associated with sex
differences, placental ACE-2 and levels of the AT1-AA.

Public health relevance
Project Narrative. Women with hypertensive pregnancies have systemic inflammation, impairments in cerebral hemodynamics, blood-brain barrier damage, and neuroinflammation. The studies outlined in this project will determine the relationship of the AT1-AA, and fetal sex to these factors.